BREATHE - Bridging Research, Lung Health, and the Environment - Children's Center

The Children's Environmental Health Research Centers have made significant contributions to defining
environmental risk factors and developing interventions to reduce risk. Successful translation of this work has
the potential to amplify discovery to improve the lives of millions of infants and children. The Center for Childhood
Asthma in the Urban Environment was established in 1998 as one of the original Centers and has focused on
childhood asthma and respiratory disease for over twenty years. The BREATHE (Bridging Research, Lung
Health, and the Environment) Children's Center will translate findings, based on our own work and work from
other centers, regarding environmental exposures that impact children's respiratory health and interventions to
reduce risk. The NIEHS translational framework will be applied to put science into practice with novel, evidence-
based communication strategies that inform and engage students, community members, health professionals,
and policymakers to reduce harmful exposures and promote children's respiratory health. The Program will be
overseen by the Administrative Core (Director: Dr. McCormack, Deputy Director: Dr. Burke) which will provide
resources, oversight, and support to successfully translate findings regarding children's environmental
respiratory health from science to practice and policy. The goal of the Translation Core (led by Drs. Burke,
Galiatsatos and Surkan) will be to develop novel communication tools that build on local, state, and national
partnerships. The Kids BREATHE Lung Health Dashboard will display relevant, actionable information with map-
based visualization strategies and storyboard techniques to engage the general public. The dashboard will
synthesize decades of children's environmental health research findings to communicate knowledge about
hazardous exposures, associated health risks, and the potential benefits of interventions. The Lung Health
Ambassadors Program (LHAP) curriculum will serve as the foundation upon which we will build a curriculum
focused on children's respiratory environmental health. LHAP is a school-based health education program with
a goal to educate and empower youth to be advocates for lung health that was established in 2018 in partnership
with the Baltimore community. The LHAP curriculum will be tailored to reach students, community members, and
healthcare professionals and LHAP graduates will be channeled into a new Lung Health Corps, a volunteer
network developed to engage key partners at the local, state and national level in a coordinated advocacy
program. Finally, the BREATHE Children's Center's mission includes a deep commitment to training the next
generation of scientists engaged in children's environmental health research. The Development Core (led by
Drs. Hansel and Koehler) will expand and diversify the engagement of early career investigators conducting
children's environmental health research through pilot projects and development activities. Complementary pilot
programs will provide a mechanism to engage early investigators, to promote agility in responding to emerging
environmental hazards and to adapt new approaches to translating scientific discovery into action and policy.

Public health relevance
The BREATHE (Bridging Research, Lung Health, and the Environment) Children's Center aims to translate decades of research and put science into practice with novel communication strategies that inform and engage students, community members, health professionals, and policymakers. The Kids BREATHE Lung Health Dashboard incorporates data visualization and tracking to educate and engage the public; the Lung Health Ambassador Program delivers an educational curriculum with training to empower individuals to advocate for environmental interventions; and the Lung Health Corps provides a network of motivated volunteers to advance children's environmental respiratory health in their communities. In building these tools, the BREATHE Center investigators will engage early stage investigators from diverse backgrounds to build a pipeline of future leaders promoting children's environmental respiratory health.